Disease Modeling Unit

ABSTRACT
The Disease Modeling Unit of the BCM Center for Precision Medicine Modeling will be responsible for producing
and phenotyping the Center’s precision animal models. The Unit will use advanced genome editing and
modification techniques and phenotyping workflows developed by our existing animal modeling programs to (1)
produce mouse and fly models that recapitulate human disease-associated variants and (2) validate variant-
disease associations, identify disease mechanisms, and test putative interventions in fly and mouse models.
Moreover, the Unit will screen sequencing data from rhesus macaque colonies to identify animals with putative
disease-associated variants in genes of interest. The Unit will undertake three Demonstration Projects intended
to showcase the proposed Center’s ability to model undiagnosed and rare diseases affecting a variety of organ
systems at different ages of onset and to translate model organism findings back to patient care. These
nomination projects will integrate mechanistic studies in the fly with phenotyping and intervention studies in the
mouse to demonstrate the fly and mouse model production capacity, breadth of phenotyping capabilities, and
potential translational impact of models generated by the Center. Together with the Bioinformatics and
Preclinical/Co-Clinical Sections, the Unit will also participate in the human disease-associated variant nomination
process by identifying the correct precision animal model (e.g. fly, mouse) and by identifying phenotyping
strategies that answer clinically relevant questions posed by local and external nominators. The Unit will also
assess whether a putative rhesus macaque model is available for each nominated variant. When nominated
variants are selected for modeling, the Unit will work closely with the Resource and Service Section during project
planning to ensure that the correct models are selected, and a rigorous study plan is enacted. Overall, the goal
of studies performed using the Unit’s precision models will be to uncover new disease mechanisms, reveal new
disease biomarkers and phenotypes, and identify potential new therapeutic strategies for patients.